In vivo cell engineering for HIV cure.

ABSTRACT
Many innovative gene and cell therapy strategies are being considered for an HIV cure. However, for a cure to
be acceptable to people living with HIV (PLWH), it must not only be effective, but also have a favorable profile
of safety/toxicity, cost, practicality and accessibility. In this Program Project we are focused on developing an
HIV cure that would be acceptable to PLWH, with a path towards greater accessibility, including for low and
middle-income countries. To do this, we are taking advantage of significant recent innovations in gene and cell
therapy technologies, which have included contributions from the members of this team. Specifically: (1) new
gene therapy vector formulations and gene editing tools that support targeted in vivo editing to precisely modify
hematopoietic stem cells (HSCs), T cells and B cells; (2) surface accessible bone marrow cryogel ports that
further facilitate in vivo cell engineering, and which can also direct the differentiation of engineered cells; (3)
chemotherapy-free conditioning regimens based on epitope editing that allow both selection of engineered cells
and a reduction in the HIV reservoir; and (4) a portfolio of broadly-acting and validated anti-HIV reagents that
can be used in combination to control HIV. To do this, we have assembled a multi-PI academic team with long-
standing collaborations and who are innovators in these areas. The three interacting projects, Project 1/Kiem,
Project 2/Cannon and Project 3/Scadden, will be supported by an Administrative Core and a Nonhuman Primate
Core that brings extensive expertise in the evaluation of gene and cell therapies in SHIV-infected rhesus
macaques. We are also supported by a network of industry partners who will contribute intellectually and provide
expertise and reagents in key technologies and will facilitate the translational development of our approaches.
The project will be organized with the following 4 Overall Specific Aims:
Overall Aim 1. Identify an optimal strategy to select for engineered HSC and also deplete the HIV reservoir.
Overall Aim 2. Identify the best vector approaches for in vivo engineering of HSC and B cells.
Overall Aim 3. Evaluate the use of a novel organoid for in situ delivery of anti-HIV vectors.
Overall Aim 4. Identify the best combination of anti-HIV approaches, based on CCR5 knockout, expression of
broadly acting HIV inhibitors and direct targeting of the integrated provirus.

Public health relevance
NARRATIVE Here we propose to develop a gene therapy approach for an HIV cure that can be delivered directly in vivo with a simple injection. This would allow for a much greater accessibility of an HIV cure approach for people living with HIV, including those in low and middle-income countries.